Pediatric and Adolescent Gynecology Training Program

The NICHD Fellowship in Pediatric and Adolescent Gynecology (PAG) is comprised of faculty from three institutions: The National Institute of Child Health and Human Development (NICHD), MedStar Washington Hospital Center (MWHC) and Childrens National Health System (CNHS). Previously housed at MedStar Washington Hospital Center, the Pediatric and Adolescent Gynecology Fellowship has been training fellows since 2010 with the mission to ensure the graduate possesses the knowledge, skills, and professional attributes essential to be able to function as a consultant to pediatricians, family practitioners, obstetricians and gynecologists for girls from birth up to age 18-21 years with pediatric gynecologic concerns as well as older women born with congenital anomalies. Pediatric and Adolescent Gynecology is closely related to Reproductive Endocrinology and thus this program will be synergistic with the existing Fellowship in Reproductive Endocrinology and Infertility.

Of Note: The Pediatric and Adolescent Gynecology Program consists of a Fellowship Program as well as Research program. Faculty from the fellowship program spend 30% of their time doing research but their salaries are fully budgeted under the fellowship CAN. A Clinical Research Coordinator and a Postbac IRTA are also currently budgeted under the fellowship CAN and will be moved to the Lab CAN for FY2023.